Cellular organization, division, and differentiation in an ancient, genetically reduced bacterium

Project Summary / Abstract
In this proposal we aim to define the molecular mechanisms of division and differentiation in a phylum that
consists entirely of bacterial species that live in osmotically stable, intracellular environments. During
adaptation to intracellular life, microbes often exhibit a significant reduction in their genome size, resulting in
the loss of metabolic and structural elements that are not required for life within a host cell. The bacterial cell
wall, composed of peptidoglycan, protects most bacterial species from osmotic stress and is essential for cell
division. Peptidoglycan also determines a bacterial cell’s shape, and by directing its synthesis and degradation
microbes can effectively control cell size and differentiation between developmental forms. Nascent
peptidoglycan biosynthesis is spatially and temporally restricted within bacterial cells via two known molecular
complexes: the MreB complex, which is primarily associated with bacterial cell wall synthesis, and the FtsZ
complex, which is associated with septal peptidoglycan synthesis required during cell division. Members of the
Chlamydiae do not encode FtsZ and have long been thought to completely lack peptidoglycan. We recently
discovered that several members of the Chlamydiaceae synthesize peptidoglycan but do not use it to form a
canonical cell wall. Instead, these microbes utilize only septal peptidoglycan in their replicative forms, which is
maintained, paradoxically, by an MreB complex. Here we propose a series of studies to investigate how
members of the Chlamydiaceae temporally and spatially restrict peptidoglycan synthesis throughout the
division process, efficiently controlling cell size, division, and the transition between developmental forms.
Over the next five years we plan to increase our understanding of these fundamental processes by focusing on
three major areas of investigation: 1) Identifying the mechanisms that direct and influence peptidoglycan
synthesis and degradation in the absence of FtsZ, 2) characterizing polar localizing features present in
Chlamydia and assessing their role in orienting peptidoglycan and the cell division complex, and 3)
establishing the critical factors that influence bacterial cell size in an osmotically stable environment during the
course of normal development and in response to cell stress. Genetically reduced microbes are attractive
models for identifying the fundamental components of essential physiological processes. These planned
studies will elucidate not only how genetically reduced microbes regulate cell size and divide in osmotically
stable environments, but also illuminate the inherent versatility of the broadly conserved molecular complexes
underlying these process.

Public health relevance
PROJECT NARRATIVE Bacterial division and differentiation are carried out by intricate, molecular machines that are spatially and temporally regulated. Most of our knowledge regarding these processes is restricted to ‘model organisms’ whose genomes tend to encode highly complex structural and regulatory systems that are often absent in more genetically-reduced organisms. The work proposed here outlines a series of studies to address how more minimalist microbes carry out these basic, cellular processes, and assess the capabilities inherent to the molecular complexes conserved between ‘model’ and ‘non-model’ microbes.